Role of Gut-Immune Interactions in Aging-Associated Bladder Cancer

ABSTRACT
Bladder cancer (BCa) is predominantly a disease of aging with the risk of developing invasive disease peaking
in the 8th decade of life. Elderly patients have higher rates of co-morbidities and are thus often not suitable
candidates for standard of care surgery and/or chemotherapy or immunotherapy. Moreover, unlike other cancers
such as breast and colon, BCa in the elderly is more aggressive and associated with poorer outcomes. Aging is
also associated with both increased baseline levels of tissue inflammation and major differences in the gut
microbiome. Aging-associated changes in the microbiome and inflammation have been linked to cancer
incidence and progression, and poorer outcomes with immunotherapy and chemotherapy in multiple cancers. In
spite of the numerous studies describing these changes, mechanistic studies attempting to understand how
these changes impact BCa are comparatively absent. To investigate this phenomenon in a translational setting,
we exposed young (8 weeks at start) and older mice (78 weeks at start) to the model BCa carcinogen N-Butyl-
N-(4-hydroxybutyl) nitrosamine (BBN). We found older animals had increased baseline levels of inflammation
and developed larger, more aggressive tumors after 16 weeks of BBN. Older animals also had more inflamed
tumors as we found higher levels of recruited neutrophils and macrophages. Innate immune cells, particularly
neutrophils, have been associated with a pro-tumorigenic phenotype in colon, liver, and other cancers and thus
we proposed altered inflammation may be a cause of the larger tumors. As aging results in major changes in
microbial diversity, we also evaluated 16S sequencing of the fecal microbiome to determine if these animals
underwent similar changes. While the microbiomes were similar at the start of the study, we found major
divergences between the groups over time, with significant differences in ß-diversity between young or old
animals with cancer. This has led to the hypothesis that gut dysfunction drives neutrophil recruitment to enhance
BCa formation in aged animals. In Specific Aim 1, I will assess gut dysfunction and microbial divergence over
time in young and old animals. In Specific Aim 2, I will use fecal microbiota transplantation to determine if
switching microbiota constituency between young and old animals during tumor formation can affect BCa
tumorigenesis. In Specific Aim 3, I will use pharmacological and genetic inhibition of specific aspects of neutrophil
biology to evaluate the role of neutrophils in BCa development in young and old mice. Completion of these aims
will provide the first murine model for aging related increases in BCa. Moreover, this research sets the stage for
future R01 studies aimed at detailed mechanistic studies understanding the signaling mechanisms that mediate
these observations as well as studies using combination therapy with immunotherapy as a novel treatment for
BCa. Dedicated time to perform these studies will serve as the critical preliminary data to propel the applicant,
Dr. Ben Woolbright, towards an independent career.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Bladder cancer is a tumor associated with aging. We have hypothesized this is due to increased inflammation that drives cancer formation and progression in aged patients or aged animals and that this may be related to age associated alterations in the gut microbiota. We hope to reduce this inflammation through direct interventions against neutrophils or through microbial transplantation.